Multi-Site Clinical Data to Power MRI Biomarker of Neonatal Brain Injury

Abstract
This project aims to release our recently gathered existing clinically-acquired data for neonatal hypoxic ischemic
encephalopathy (HIE). HIE affects 1-5/1000 term-born neonates and is a major cause of early-childhood
mortality and morbidity. Neonatal brain magnetic resonance imaging (MRI) is acquired routinely for the clinical
care of HIE. Neonatal brain MRI is expected to reveal 3D neuroanatomic mechanisms of adverse outcomes so
that we can design new treatments specifically target those mechanisms. Neonatal brain MRI also carries hope
to identify those neonates who are at risk to develop adverse outcomes later in life, so that early intervention
program can target those at-risk neonates for maximum benefit. Despite MRI's vital role in caring for HIE, the
current norm in clinical practice is to read MRI visually by expert neuroradiologist or neurologist. Expert reads,
however, has many limitations – subjective, qualitative, insufficient to reveal mechanisms, and inadequate to
predict outcomes. Objective and quantitative analysis of MRI is possible with the rise of artificial intelligence (AI)
in medical and neuroimaging informatics. A major limitation, however, is the lack of publicly-available data on
HIE. Our project aims to fill this gap, by archiving and releasing our clinically-acquired, large-scale (N=231), and
multi-site (2 hospitals) data on HIE. Our data was acquired partly funded by NIH R01 (2012-2017) and
foundations (2016-2020). Our data is comprehensive, including clinical data elements (from both mothers and
neonates), neonatal brain MRI (structural and diffusion sequences), expert-consensus annotation of lesion
regions in neonatal brain MRI, NICU outcome (death/survival, length of stay), and 2-year-old neurocognitive
outcomes (normal/adverse, yes/no for development dealy, yes/no for the hearing/visual/motor impairment, and
yes/no for cerebral palsy). Our data is also representative, coming from patients with different racial/ethnicity
groups, in patients with a wide range of outcomes, from different MRI scanners (Siemens 3T or GE 1.5T), with
different imaging protocols, and MRI scanned on different days of life. We will also derive new data from existing
data. The anonymized (de-identified) data will be released to the NCBI dbGaP platform with the “Controlled
Access” option, requiring IRB and data use agreement (DUA). The derived data will be released to dbGaP with
the “Open Access” option, freely downloadable without any approval. Both release options are consistent with
other clinical and MRI data that have already been released on dbGaP. We hope this first comprehensive data
will boost future collaborative efforts for AI to automatically identify HIE lesions in MRI, and for AI to accurately
predict HIE outcome integrating clinical and MRI information.

Public health relevance
Project Narrative We aim to publicly release our existing clinically-acquired data for neonatal brain injury caused by hypoxic ischemic encephalopathy (HIE). Our data were retrospectively collected partially funded by NIH R01 (2012-2017) and two other foundational/institutional grant (2016-2020); our data is comprehensive (clinical data from mothers and neonates, neonatal brain MRI with expert-consensus annotations of HIE lesions, and complete set of outcome measures by 2 years of age); our data is representative (MRI scanner, age at MRI, MRI protocol, patient outcomes, patient racial/ethnicity groups); and our data is multi-site (2 hospitals) and large-scale (N=231 compared to proprietary studies with dozens of patients). We plan to use this first public clinical and brain MRI data for HIE to boost artificial intelligence (AI) research for HIE lesion detection and outcome prediction, toward promoting outcomes in this vulnerable neonatal population.